The Economics of Special Education for Individuals with Developmental Disabilities including Down Syndrome

About 7.3 million individuals with developmental disabilities receive special education at a federal cost of $18.4
billion annually. While special education focuses primarily on learning, it also provides health-related services
and increases well-being through social interaction and inclusion. When special education as a public
entitlement ends, ages as early as age 18 or as late as age 25, depending on the state, individuals lose health-
related services. Qualitative evidence suggests that about 60% of individuals are not enrolled in education
programs, vocational rehabilitation, or employed after exiting special education, suggesting low levels of social
interaction and inclusion. In response, ten states recently extended the age at which special education is
mandated to end, and several other states are considering legislation to do the same. However, the costs and
benefits of extending special education are unclear. There is no quantitative work accounting for differences
across states or selection bias. As a health economist, I am skilled at applying causal inference methods in
large administrative datasets. A K01 award will enable me to achieve my long-term career goal of creating
evidence to shape healthcare policies supporting individuals with developmental disabilities, focusing on Down
syndrome. The training plan will expand my knowledge of Medicaid data and policy, special education, and the
diversity of experiences for individuals with developmental disabilities through fieldwork, coursework, and
working groups. An interdisciplinary mentorship team with deep knowledge of individuals with developmental
disabilities via lived experience, clinical expertise, and Medicaid data and policy expertise will support the
training. It will directly inform the research through three aims: Aim 1: Describe the cohort of individuals with
developmental disabilities in Medicaid data aged 10-24 across all 50 states, making aggregated totals publicly
available. Aim 2: Quantify how aging out of special education impacts health outcomes and utilization for
individuals with developmental disabilities while controlling for individual-level factors. Aim 3: Examine the
differential impact of aging out of special education by impairment type, geography, race, and ethnicity. The
K01 will enable me to become an independent investigator answering critical policy relevant questions for
transition age youth with developmental disabilities, focusing on Down syndrome. Results will provide
actionable data guiding policymakers, clinicians, researchers, and advocates. For example, results will inform
current policies extending special education to later ages. If aging out of special education adversely impacts
one’s health, it may make sense to federally expand special education to later ages or to provide additional
resources to minimize the effect of the transition. Findings will support the development of an R01 proposal
studying the impact of losing special education on long-term health with a focus on potentially protective
factors or especially historically and socially marginalized subgroups, such as those with Down syndrome.

Public health relevance
About 7.3 million individuals with developmental disabilities receive special education at a federal cost of $18.4 billion annually. While special education focuses primarily on learning, it also provides health-related services, including speech-language, occupational, and behavioral health therapy, and increases well-being through social interaction and inclusion. Losing special education—which occurs across all states at ages ranging from 18 to 25—may therefore disrupt the provision of health-related services and well-being.